NONINVASIVE HEMODYNAMIC MONITORING IN THE EMERGENCY DEPARTMENT

Determine in which clinical setting noninvasive hemodynamic monitoring is most useful in the Emergency Department, determine the impact of noninvasive hemodynamic monitoring on physician clinical decision-making in the ER, and determine physician acceptance of noninvasive hemodynamic monitoring.